PLACEBO CONTROLLED TRIAL OF THALIDOMIDE IN PATIENTS WITH TUBERCULOSIS OR AIDS

This study will evaluate the mechanism of action od thalidomide to selectively inhibit release of tumor necrosis factor (TNF) in patients with tuberculosis and/or HIV infection. It will assess the safety and efficacy of thalidomide, as judged by symptoms, physical examination, and studies of microbiological, immunologic, hematological, renal, and hepatic status.